Early GABAergic signaling influences axon morphology and cortical cell polarity

PROJECT SUMMARY
Brain development is a complex process that requires the production and differentiation of numerous cells and
cell types, with the additional challenge of spatial and temporal precision in the neural circuitry that connects
these cells. Improper formation of neural circuitry leads to impaired control over brain activity patterns and is
broadly thought to contribute to a number of childhood neurological disorders. Multiple lines of research suggest
that inhibitory GABAergic circuitry in particular contributes to the pathophysiology of neurodevelopmental
disorders, yet symptoms of intellectual disability (ID), and epilepsy common in these disorders remain poorly
treated. Our prior work has identified the GABAA receptor α2 subunit as central to human ID syndromes caused
by mutations in genes known as ARHGEF9 and NONO. We have found that impairments in α2 expression and
localization lead to impaired specification of subtypes of inhibitory synapses in models replicating features of
human syndromic ID. In studying these models, we also identified abnormalities in cortical cell morphology and
cortical organization suggestive of dysfunction in earlier developmental processes. A role for the GABAA receptor
α2 subunit in early developmental stages is further supported by its notably high level of expression in early
neurodevelopment, well before synapses are formed. On this premise, we hypothesize that both early
trophic signaling and later synaptic signaling via the GABAAR α2 subunit are necessary for typical
cortical development, with dysfunction in each contributing to distinct phenotypic features of ID
syndromes. In this proposal we will manipulate either the GABAA α2 subunit (aim 1), ARHGEF9 (aim 2), or
NONO (aim 3) and examine: (i.) early developmental stages of process outgrowth, neuron polarization, and
spine formation in vitro, as well as (ii.) tissue level features such as cortical organization, cell morphology, and
synapse specification in vivo. These complementary approaches are expected to provide comprehensive
information about the mechanisms of discrete but interdependent developmental processes necessary for typical
cortical development, with implications for non-typical cortical development seen in neurodevelopmental
disorders. Relevance to human health: The proposed project is expected to yield detailed information about
neurodevelopmental stages ranging from process outgrowth to synapse formation and specification in both
typical and non-typical conditions, providing both basic knowledge about brain development, and translational
insights for neurodevelopmental disorders. Outcomes: This rigorous and impactful work will be conducted
entirely by undergraduate and graduate students at UNLV, which is one of the nation’s most diverse campuses.
Thus, beyond scientific outcomes, this project will provide instrumental training opportunities for the
diversification of the biomedical workforce, as well as enhance the research environment of our institution.

Public health relevance
PROJECT NARRATIVE This project aims to delineate the signaling mechanisms that regulate early processes necessary for the typical development of the cortex. The proposed research has implications for understanding the underlying causes of intellectual disability, which is a core feature of numerous human neurodevelopmental syndromes. This project also supports the inclusive training of undergraduate and graduate students focused on neuroscience and neurodevelopment research at UNLV, which is consistently ranked as one of the nation’s most diverse campuses.